Quinolone and acyl-homoserine lactone quorum sensing in chronic P. aeruginosa infections

Project Summary
Quorum sensing (QS) is a cell-cell communication system used by many bacteria to regulate gene
expression in a coordinated manner. Our work focuses on the QS system of Pseudomonas aeruginosa,
a saprophyte and opportunistic pathogen of humans. P. aeruginosa uses QS to regulate dozens of
genes, including several important virulence factors. P. aeruginosa QS is mediated by the transcription
factors LasR and RhlR, which respond to acyl-homoserine lactone signals, and PqsR, which responds to
alkylquniolone signals. Initial characterizations of QS in P. aeruginosa described a hierarchy: LasR
regulates RhlR and PqsR activity. Over the past several years we, and others, have shown that this
hierarchy is malleable. RhlR and PqsR can be active in the absence of functional LasR in isolates from
many settings, particularly those isolated from the chronic lung infections of people with cystic fibrosis
(CF). These results suggest a “rewiring” of QS that is critical to the maintenance of virulence functions in
chronic infections.
This proposal builds on our previous observations to ask about the biological significance of this alternate
hierarchy in bacterial isolates from people with CF. We make use of CF isolates and a laboratory model
strain to ask i) how is the architecture of QS of P. aeruginosa altered?; ii) in this altered hierarchy, how
do RhlR and PqsR QS interact to effect virulence functions in isolates from chronic infection?; and iii)
what is the role of a highly-conserved, uniformly QS regulated, non-ribosomal peptide synthetase?
The answers to these questions will define the central importance of RhlR and PqsR in P. aeruginosa from
chronic infections and inform future efforts to design therapeutics targeting RhlR or PQS QS in this
bacterium.

Public health relevance
Project Narrative Pseudomonas aeruginosa, a bacterium that infects people with immune compromise, engages in a process of cell-cell communication called quorum sensing. This project seeks to answer how quorum sensing changes in people with chronic infections, with the idea that these studies will eventually lead to development of new therapies for bacterial infections.